Baylor Pediatric Diabetes Research Training Program

DESCRIPTION (provided by applicant): The objective of the Baylor Pediatric Diabetes Research Training Program is to provide didactic structure and mentoring for post-doctoral M.D. fellows, who are committed to academic careers in pediatric diabetes research and care. Our program's strength lies in the availability of the resources of one of the largest Departments of Pediatrics in the country, which include: 1) well established, peer review funded, investigators with broad disciplinary expertise and a track record of mentoring; 2) excellent research resources, programs and facilities; and 3) new leadership in the section of pediatric endocrinology and metabolism; 4) range of multi-ethnic patient population. In addition, Baylor College of Medicine provides a rich environment of basic and clinical expertise, which will provide unique training opportunities for pediatric diabetologists. The proposed training plan will: 1) facilitate the development of their individual didactic and research training programs; 2) provide stipends to protect time for their individual research and educational efforts; 3) provide educational support in the area of study design, statistics, molecular biology, and/or other cognates; 4) assure an appropriate and successful Mentor match; and 5) make available the resources of the Department and Baylor College of Medicine to facilitate their research activities in a cost effective fashion. The proposed program has 27 clinical and basic science investigators as potential mentors. All mentors have active research programs and vast majority of them have expertise in mentoring physician-scientists. During the first year of clinical training, Scholars will, with the help of the program director, develop a 2-5 page research proposal with their mentors as part of their applications to this program. All applications will be reviewed by an Executive Advisory Committee selected from the overall mentoring faculty. The educational support is derived from the clinical and basic science curricula at Baylor, together with divisional and departmental seminar series. Over the last 10 yrs we have successfully used this approach to mentored research training for the academic development of pediatric faculty in the Children's Health Research Center grant which has fostered the career development of 32 physician investigators, of which 80% remain in academic medicine, 21 of which are current members of the Baylor faculty. We believe this success reflects the departmental and institutional commitment to the training of young physician scientists. The funding of this program will help train a unique group of academic pediatricians who will improve the long-term health of the next generation of children with diabetes mellitus, through their research efforts